Deep Behavioral Phenotyping of Novel Zebrafish Epilepsy Models

Project Summary/Abstract (from Parent R21NS138525)
Patients diagnosed with genetic epilepsies suffer with severe seizures, neurobehavioral deficits and the
uncertainty of a lifetime with diminished quality-of-life. Epilepsy in this population remains poorly controlled
despite multiple antiseizure medications and is considered one of the greatest therapeutic challenges in the field.
Despite tremendous effort, there remains a crucial need to study these epilepsy conditions at a preclinical level
so we can identify new and safe drug treatments. Zebrafish mutants designed to represent these human genetic
conditions would provide valuable tools for elucidating basic disease mechanisms and drug discovery. As such,
we recently used CRISPR/Cas9 editing techniques to generate 37 different stable loss-of-function zebrafish
mutants representing a broad spectrum of these epilepsies (Griffin et al. 2021). In this R21 proposal, would
propose computational phenotyping of 12 different zebrafish mutants (arxa, cdkl5, chd2, depdc5, gabrb3,
gabrg2, gnao1, pnpo, pcdh19, scn8a, stxbp1b, and syngap1b) and initiation of a program for large-scale drug
screening. Using a recently developed high-resolution imaging system and machine learning based algorithms,
this proposal offers an unbiased approach to behavioral phenotyping and drug discovery. This first-of-its-kind
strategy could lead to a better understanding of a wide variety of currently intractable genetic epilepsies and new
drug candidates for patients suffering with these conditions.

Public health relevance
Project Narrative (from Parent R21NS138525) With nearly 68% of all epilepsies now thought to have a genetic cause, including many childhood epilepsies that are in desperate need of more effective therapies, our proposal is squarely focused on a timely and significant unmet need in the epilepsy community. While it is possible to generate mutant mice for all known human epilepsy genes, doing so would be time consuming, expensive and labor intensive. An alternative pre-clinical animal model, zebrafish offer significant advantages for in vivo analysis of gene function and drug discovery.